Biochemical Analysis of Human CD4 T cell Subsets

[unreadable] DESCRIPTION (provided by applicant): The long-term goal of the proposed research is to examine how biochemical signaling changes determine effector and memory generation and function. Understanding the mechanisms whereby memory immune cells are generated and maintained is central to developing therapies to enhance memory responses in vaccine design and eliminate memory cell function in autimmune diseases. Our central hypothesis is that distinct signaling pathways initiated at the T cell Receptor control the generation and function of effector and memory CD4 T cells. Proposed are experiments designed to examine the mechanisms by which activation signals initiated at the TCR are coupled to downstream signaling intermediates resulting in the distinct function of effector and memory T cells. The specific aims for the proposed research include defining the roles of FcR gamma and Syk in effector T cell signaling and function, analyzing differential TCR-mediated signaling in effector and memory CENT cells, and determining the membrane organization of signaling intermediates in naive, effector and memory CD4 T cells. Characterizing the signaling pathways of these T cell subsets may lead to the identification of molecular targets for immunomodulation of T cell function. [unreadable] [unreadable]